UC San Diego Raising Advancement and Parity for Infectious Disease Researchers (RAPID) Faculty Development Program

Abstract
Improving the demographics of the biomedical workforce is critical for enhancing educational experiences,
fostering scientific discovery and innovation, increasing the benefit of research on health disparity populations
and public trust. While academic institutions have an important role in this mission, the representation of faculty
from underrepresented backgrounds is low and has remained stagnant. The overall goal of the UC San Diego
(UCSD) Raising Advancement and Parity for Infectious Disease Researchers (RAPID) Faculty Development
Program is to improve the demographics of the biomedical research workforce in infectious diseases. The UCSD
RAPID Program will provide effective mentorship, activities to develop critical academic skills and research
training experiences to participants to enhance their development of successful research programs focused on
infectious diseases and success in obtaining independent extramural funding. RAPID will recruit
underrepresented early career faculty and transitioning postdoctoral scholars from a national pool to participate
in professional skill and research development activities in a summer institute program. The RAPID program is
directed by two principal investigators (PIs) and four co-investigators (co-Is) with extensive experience in
mentoring and training postdoctoral scholar, residents and junior faculty and success in creating and
implementing faculty development and mentoring programs specifically for underrepresented trainees. The PIs
/ co-Is have successfully led extramurally funded training programs; and are actively engaged in NIH-sponsored
infectious diseases research; five of the PIs are from backgrounds underrepresented in the biomedical research
workforce. The specific objectives of the UCSD RAPID Program are to enhance the demographics of the
biomedical workforce by providing participants with critical academic skills to enhance their success in
developing multidisciplinary research programs focused on infectious diseases. We propose three specific aims.
Aim 1. To improve the demographics of the biomedical workforce by continuing to recruit underrepresented early
career faculty and transitioning postdoctoral fellows from local and national pools who have infectious diseases
scientific expertise aligned with those of our research mentors. Aim 2. To continue to enhance professional skill
development and effective mentorship of early career infectious disease researchers by utilizing evidence-based
strategies including a faculty research and career advancement plan, effective mentorship and by improving
knowledge and skills in various professional development areas important for academic and research success.
Aim 3. To continue to improve research training and research self-efficacy of mentees through immersion in
effective strategies to enhance the development of robust research programs, acquire sustainable grant writing
skills and success in obtaining extramural funding. The aims proposed in the UCSD RAPID Program renewal
will continue to enhance participants academic and research success, and in obtaining independent NIH or
equivalent funding to support multidisciplinary infectious disease research.

Public health relevance
Narrative The UCSD Raising Advancement and Parity for Infectious Disease Researchers (RAPID) faculty development program will successfully mentor underrepresented early career faculty and transitioning postdoctoral scholars and develop sustainable skills to enhance their research progress and success in obtaining independent NIH or equivalent funding. The overall goal of the RAPID program is to improve the demographics of the biomedical research workforce.